Pre-clinical Translational Research Facility

PTRF group continue to support the animal experiments for the entire NOB. PTRF works with the individual research group to design the animal experiments and provide their experts opinion. Once the experiments are approved by the branch chief, PTRF will establish the animal models, administer the drugs per protocol, and monitoring the treatment responses by imaging or survival measurement. They also take care the daily examination for the animals to ensure their well being. Following the experiments, PTRF provide service of tissue harvesting, processing and survival data analysis.